Power and sample size for generalized linear models

PROJECT SUMMARY / ABSTRACT
This project responds to FOA PA-21-235. A variety of well-characterized and valid methods for power and sam-
ple size (PSS) estimation in generalized linear models (GLM) have been developed. These are primarily in the
area of linear models for continuous data and logistic regression for binary data. By and large, methods that are
more general require a prior speciﬁcation of several study-speciﬁc details in order to be implemented in a par-
ticular application, and this can pose challenges for applied statisticians and non-statistical collaborators. These
challenges have impeded the study design of translational mental health research, randomized clinical trials in
psychiatric populations, and other investigations that involve GLM in ways that linear models do not. To overcome
these challenges, the overarching goal of this project is to develop methods for estimating power, needed sample
size, or minimally-detectable effect size in study designs involving GLMs. To be broadly useful, such methods
should be accurate, interpretable, and, importantly, easily-speciﬁed.
This project offers, in the framework of GLMs, a general formulation with the aim to recapture, to close approx-
imation, features of the common approach to PSS for linear models, namely the use of partial multiple R-squared
as a general measure of effect size. This is accomplished by introducing two GLM analogues of R-squared. Local
and more distal alternative hypotheses are considered, the latter requiring more attention to yield accurate re-
sults as the alternative hypothesis moves further from the null. Both Wald and score tests (which coincide under
linear models) are also considered. This project has three speciﬁc aims: Using novel GLM analogues of multiple
partial R-squared for linear models, develop approaches to estimate power, needed sample size, or minimally
detectable effect size for Wald (Aim 1) and score (Aim 2) tests to be conducted in the framework of GLMs. Aim 3
is to develop, test, document and disseminate software implementing the new methods. The developed methods
are guided by and applied to two collaborative projects in translational mental health.
The expectation is a new and general suite of applicable and usable approaches to power and sample size es-
timation for the “bread-and-butter” class of generalized linear models forming the foundation of so many analysis
methods in modern biomedical and public health investigation.

Public health relevance
PROJECT NARRATIVE In biomedical and public health studies, careful planning is critical to ensure robust scientiﬁc results as well as efﬁ- cient use of resources. Part of that process involves estimating the sample size needed to obtain statistical results at the needed level of precision. This project develops new methods for estimation of sample size and statistical power in the widely-used “bread-and-butter” generalized linear models class of statistical analysis methods.